CANCER CENTER SUPPORT GRANT (COMPREHENSIVE)

This is a proposal for a renewal of the existing cancer center support grant (comprehensive) for the Fred Hutchinson Cancer Research Center of Seattle. Support requested will continue the development and maintenance of support for professional personnel, administration, shared resources and services, developmental funds, equipment, supplies, clinical oncology units and indirect supports for community and cancer control programs. Basic science programs involve tumor immunology, both basic and clinical, biochemical oncology, medical oncology and various subdivisions, viral oncology, developmental biology, cellular biology, and oncologic genetic research. Clinical programs of the Medical Oncology Unit have both basic as well as supportive services for all aspects of marrow transplantation as well as clinical and basic studies in the treatment of lung, melanoma and other forms of cancer, and pediatric research into both clinical and basic aspects of cancer. Pediatric research is conducted both at the Center and at Children's Orthopedic Hospital and Medical Center. Epidemiology and biostatistics programs include the SEER and SAQC projects. The Fred Hutchinson Cancer Research Center is a comprehensive center which first opened in its current facilities September, 1975. The Center is an independent free-standing, non-profit corporation governed by a Board of Trustees. The Center has and continues to receive strong community support from business, labor, affiliated educational institutions, particularly the University of Washington, voluntary groups including the American Cancer Society, regional as well as local hospitals and practicing health professionals. Programs of the Center involve communities and lay groups from which support is received.